GENCODE: comprehensive gene annotation for human and mouse

PROJECT SUMMARY/ABSTRACT
The GENCODE project is focused on the generation, expansion, and maintenance of high-quality reference
gene sets for human and mouse, which are critical for genomic research. Our work will prioritise the continued
refinement of the reference gene sets, incorporating long-read sequencing data, ribosome profiling, constraint
data, and draw on collaborative efforts such as the MANE project. This will ensure that the annotations remain
comprehensive and accurate, addressing both existing and novel genes while incorporating evolutionary insights
and functional data.
Additionally, we aim to expand GENCODE's scope by expanding our annotations to the human pangenome.
With the completion of a draft human pangenome and first T2T (telomere-to-telomere) human genome, the
genomic landscape has changed significantly, highlighting the need for accurate gene annotation across diverse
human haplotypes. GENCODE will apply manual annotation and semi-automated approaches to ensure that the
genetic diversity represented in the pangenome is accurately annotated across different haplotypes. This will be
critical for the long term goal of clinical adoption of the pangenome.
We will also significantly enhance the annotation of non-canonical open reading frames (ncORFs) using
ribosome profiling (Ribo-seq). These regions, often overlooked, may play significant regulatory or functional roles
in disease and cellular processes. GENCODE will focus on cataloguing ncORFs across different cell types. We
will analyse these ncORFs from the perspective of both evolutionary and human variation constraint and to
highlight both conserved ncORF which may be functional and those potentially involved in disease.
Lastly, GENCODE data will be made more AI-ready and FAIR-compliant (Findable, Accessible, Interoperable,
and Reusable). By improving metadata and providing machine-readable datasets, we will maximise the utility of
GENCODE data for both academic research and clinical applications. We are committed to community
collaboration and feedback, ensuring that the data produced aligns with the diverse needs of genomic consortia,
industry, and the broader research community.

Public health relevance
PROJECT NARRATIVE The GENCODE project will contribute to public health by enhancing the accuracy and comprehensiveness of genomic annotations, which are foundational to understanding human biology and disease. This knowledge supports advances in precision medicine, enabling better identification of genetic variants linked to disease and improved therapeutic strategies. By extending our annotations to the human pangenome and ensuring more accessible and AI-ready data, the project will accelerate genomic research and facilitate the development of less biased and more personalised treatments, ultimately leading to improvements in human health.